Core A: Administrative and Clinical Services Core (ACS)

ADMINISTRATIVE AND CLINICAL SERVICES CORE: PROJECT ABSTRACT
The Director of the Administrative and Clinical Services (ACS) Core will be Dr. Susan Chang and the Associate
Director will be Dr. Nancy Ann Oberheim Bush. The Administrative component will be led by Dr. Chang and the
Clinical component will be led by Dr. Bush. Dr. Janine Lupo and Dr. Daniel Vigneron will serve as co-investigators
in order to provide oversight of the technical aspects of the Projects planned. Dr. Chang is the co-leader of the
Neuro-Oncology Program within the UCSF Helen Diller Family Comprehensive Cancer Center and is the overall
PI of the P01 and was as well as the director of the Administrative Core of the current cycle. She is experienced
in the coordination of multiple projects and cores and has effectively provided the leadership for the successful
activities of the P01, demonstrating clear commitment to providing oversight. The specific aims of the ACS Core
are to provide Administrative and Clinical services to all our Projects to accomplish their Specific Aims and
Research Plans. Administrative support will include fiscal, grants management and clerical support for annual
progress reports to the NCI and manuscript preparation, and organization for meetings between the key
personnel from the projects and cores, as well as for meetings with the External Advisory Board. Three of the
projects will involve patient research studies and the clinical component will provide the infrastructure and
personnel to allow the conduct of the novel imaging studies. This will include clinical scientists, neurosurgeons,
research nurses and clinical research assistants, as well as clinical space to obtain informed consent, manage,
and follow patients enrolled in clinical studies within the Projects. The overall goal of the ACS Core will be to
facilitate the interactions of the members of this P01, provide clinical research support for the Projects, and
administratively coordinate activities of the P01 investigators. The following table depicts the distribution of effort
provided to the four Projects by the two components of the ACS Core.
Anticipated Distribution of ACS Core Effort
Component Project 1 Project 2 Project 3 Project 4 Total
Administrative 25% 25% 25% 25% 100%
Clinical 20% 20% 0% 60% 100%

Public health relevance
ADMINISTRATIVE AND CLINICAL SERVICES CORE: PROJECT NARRATIVE The proposed P01 consists of four highly integrated projects and shared resources (Biospecimen and Biomarker Core and Imaging Tumor Heterogeneity & Metabolism Core) focused on identifying imaging and genomic signatures of brain tumor heterogeneity and evolution to optimize patient management of the two most common primary brain tumors in adults: glioblastoma and meningioma. This Core will provide administrative and fiscal oversight for all four projects and clinical services for the three projects that will be performing patient studies.